Core Grant for Vision Research-Animal Module Core

Animal Resource Project Summary/Abstract
Our institute’s mission is to conduct research that will lead to a better understanding, treatment
and prevention of diseases that cause visual dysfunction and blindness. To achieve these
goals, the research faculty uses a variety of laboratory animal models that are essential for
elucidating the pathogenesis of a diverse group of ocular diseases. The primary purpose of the
Animal Resource Module is to provide expertise and assistance in animal imaging and visual
assessment, devise surgical plans for novel animal models, consolidate rodent colonies as
shared resources, and to provide extensive veterinary support along with pre-, intra-, and post-
operative care. The animal resource module staff trains and provides support on the use of the
ERG, HRT, OCT, slit lamp microscopes, and fundus photography systems, and maintain and
upkeep imaging spaces and equipment. They also troubleshoot the breeding of difficult
transgenic lines, conduct the genotyping and phenotyping of mouse models that are central to
many of our research studies.